Neutrophil regulation of brown adipose tissue homeostasis

PROJECT SUMMARY
Brown adipose tissue (BAT) is a thermogenic fat pad that is essential for maintaining core body temperature and
is associated with protection from numerous metabolic diseases. Adult patients with intact BAT activity are much
less likely to have obesity, type 2 diabetes, or cardiovascular disease (CVD), and obese individuals exhibit
impaired BAT activation after exposure to cold environmental temperatures. Consequently, there is significant
interest in identifying novel pathways that regulate BAT function, with the goal of developing new therapeutic
strategies to treat metabolic diseases such as obesity and type 2 diabetes. It is well established that sympathetic
neurons are the dominant drivers of brown adipocyte activation by secreting the catecholamines epinephrine
and norepinephrine (E/NE). Macrophages then degrade Epi/NE to form a negative feedback loop that is essential
for maintaining BAT homeostasis. Recently, we characterized the immune cell landscape of BAT and surprisingly
found that neutrophils are the most abundant immune cell type in this tissue, greatly outnumbering macrophages.
However, the role of neutrophils in regulating BAT function is unknown. Neutrophils are best known for
their role in phagocytosis of bacteria and foreign material and are highly glycolytic cells with few mitochondria.
In new preliminary studies, we have found that neutrophils are recruited from the blood specifically into BAT
following exposure to cold temperatures and undergo massive metabolic and transcriptional reprogramming to
acquire a unique reliance on oxidative phosphorylation. Antibody-based depletion of neutrophils leads to
decreased BAT mass, impaired adaptive thermogenesis, and hypothermia. Strikingly, mice that are born without
any neutrophils die if subjected to cold stress but are rescued from this fate if they receive a single adoptive
transfer of wildtype neutrophils into the BAT. In addition, we found that the recruitment of neutrophils into BAT is
dependent on ATG14, and deletion of ATG14 in myeloid cells leads to decreased core body temperature,
decreased BAT mass, loss of stored lipids in BAT, decreased expression of Uncoupling protein 1, and
exacerbated HFD-indued obesity. Furthermore, neutrophils directly activate brown adipocyte metabolism. These
findings lead to our central hypothesis that ATG14-dependent neutrophils are recruited into BAT and undergo
local transcriptional and metabolic reprogramming to critically support BAT activation and adaptive
thermogenesis. We will address this hypothesis in two aims. In Aim 1, we will identify the factors that drive
neutrophil reprogramming upon entry into BAT and determine whether disruption of their metabolic reprograming
impairs BAT thermogenesis. In Aim 2, we will determine the mechanisms by which ATG14-dependent
neutrophils in BAT sustain adaptive thermogenesis to ameliorate metabolic disease pathogenesis. These studies
will identify for the first time a role for neutrophils and ATG14 in regulating BAT function and adaptive
thermogenesis, revealing a novel immunometabolic pathway that can be targeted to enhance BAT activity to
treat multiple metabolic diseases, such as obesity, type 2 diabetes, and/or CVD.

Public health relevance
PROJECT NARRATIVE Brown adipose tissue (BAT) is a thermogenic fat pad that is essential for defending against hypothermia in rodents and human babies and is severely dysregulated in adult patients with obesity and type 2 diabetes. Although many studies have shown that macrophages in BAT regulate adaptive thermogenesis and energy expenditure, our new preliminary data indicate that neutrophils are in fact the most abundant immune cell population in BAT and are necessary for normal BAT metabolism and survival in response to cold environmental temperatures. The proposed studies will investigate the mechanisms by which neutrophils regulate BAT metabolism and will identify novel immunometabolic pathways that can be targeted in future studies to boost or dampen BAT activity to treat multiple metabolic diseases, such as obesity and type 2 diabetes.